In utero treatment of Dup15q syndrome via lipid nanoparticle based gene editing

ABSTRACT
Dup15q syndrome is a neurodevelopmental disorder marked by severe intellectual disability, autism
spectrum disorder (ASD), epilepsy, and motor delays, resulting from duplications of the long arm (q) of maternal
chromosome 15. It affects approximately 1 in 5,000 individuals and is 10 times more common in people with
ASD or intellectual disability. More than half of patients with Dup15q experience epilepsy, which increases the
risk of sudden unexpected death in epilepsy (SUDEP). The primary genetic cause is maternal duplications or
triplications of the 15q11.2-q13 region, leading to overexpression of the UBE3A gene. The high medical costs
associated with caring for these chronically ill children place a significant burden on families, particularly those
with limited resources. Currently, no curative treatments exist, making the development of Cas9 mRNA therapy
delivered via lipid nanoparticles (LNPs) a promising approach. This project aims to develop a non-viral gene-
editing therapy using LNP/mRNA complexes to correct UBE3A overexpression in neural stem progenitor cells
(NSPCs) during fetal brain development. By intervening early, this therapy has the potential to prevent or alleviate
neurodevelopmental deficits, seizures, and cognitive impairments characteristic of Dup15q syndrome. Delivering
Cas9 mRNA via LNPs offers a less immunogenic, non-viral alternative to traditional viral-based gene therapy
approaches. Early removal of the duplicated 15q region may prevent or rescue Dup15q phenotypes.
Administering this therapy in utero creates an opportunity to correct the genetic defect before symptom onset,
potentially preventing neurodevelopmental damage. This approach could revolutionize treatment for genetic
disorders by addressing the root cause during critical prenatal development. In utero gene editing offers unique
advantages: 1). Stem and progenitor cells in the fetal brain are abundant and actively proliferating, which
enhances gene-editing efficiency and functional outcomes. 2). The fetal immune system is more tolerant,
reducing the risk of immune rejection of foreign gene-editing enzymes. 3). The smaller fetal size allows for
optimal dosing, improving cost efficiency, a critical factor given the financial constraints of gene editing. 4). In
utero treatment is the earliest possible intervention and is unlikely to cause germline editing after the seventh
week of gestation. Early treatment of prenatally diagnosable conditions like Dup15q syndrome could significantly
alleviate symptoms before disease onset. Achieving the goals of this project will advance this regenerative
therapy toward clinical use, providing both healthcare and financial benefits. The development of non-viral, in
utero gene editing has the potential to functionally treat Dup15q syndrome and reduce the need for intensive
medical care. While this project focuses on Dup15q syndrome, the platform technology could be applied to other
genetic disorders, making it valuable for addressing a range of conditions affecting diverse populations.

Public health relevance
PROJECT NARRATIVE This proposal aims to develop a novel, non-viral in utero gene-editing therapy using lipid nanoparticles (LNPs) to target the overexpression of the UBE3A gene in Dup15q syndrome, a neurodevelopmental disorder associated with autism, intellectual disability, and epilepsy. By delivering Cas9 mRNA via LNPs to fetal neural stem/progenitor cells (NSPCs), this approach has the potential to prevent or mitigate the severe neurodevelopmental symptoms associated with Dup15q syndrome. If successful, this therapy could transform the treatment landscape for Dup15q and other genetic neurodevelopmental disorders.